Implantable pre-metastatic niche to elucidate the impact of chemotherapy-induced metastatic relapse

Epidemiological studies indicate that chemotherapy can increase the chance of metastasis in a subset patients,
but the underlying mechanism remains unclear because of a lack of relevant experimental models. The goal of
this proposal is to elucidate the impact of chemotherapy on metastatic relapse with a tissue-­engineered
metastasis model that can capture metastatic niche evolution with a high level of molecular and cellular detail.
Inspired by the recent discovery of the pre-­metastatic niche (PMN) in major metastatic organs, we have
developed a bone marrow stromal cell–seeded microfabricated porous hydrogel scaffold that creates a richly
vascularized proinflammatory microenvironment when it is subdermally implanted in a mouse. This implantable
PMN model has been shown to attract and support the engraftment and growth of circulating tumor cells and
can be serially implanted in syngeneic naive mice for long-­term studies. The semitransparent materials of the
implant are compatible with quantitative imaging analysis via multiple imaging modalities including multiplex
immunohistostaining, CLARITY-­based optical sectioning of entire scaffolds, and intravital imaging via a skinfold
window chamber.
Our central hypothesis is that tissue inflammation and remodeling induced by chemotherapy activates
dormant disseminated tumor cells and causes them to migrate and form in situ clusters as a function of cell
number. Forming clusters could allow the cells to overcome microenvironmental regulation and regain an
aggressive phenotype. We propose three specific aims: In Aim 1, we will generate subcutaneous and hepatic
PMN models in a MMTV-­PyMT female mouse and demonstrate the long-­term evolution of metastatic niche by
serially transplanting early metastatic niche established in primary mice to secondary syngeneic FVB mice. For
this purpose, we will generate MMTV-­Luc2-­PyMT mice that allow non-­invasive long-­term bioluminescent
monitoring of metastatic relapse. In Aim 2, we will use the techniques verified in Aim 1 to observe the effect of
chemotherapy with doxorubicin on the metastatic process in serially implanted bone marrow and liver PMN
models. In Aim 3, we will apply the established algorithm to measure potency to determine if adjuvant therapy
with anti-­inflammatory (anakinra) or anti-­macrophage (clodronate) drugs reduces doxorubicin-­induced
metastatic relapse and will look at the effect of adjuvant timing. The proposed research is significant because it
has the potential to facilitate the development of better therapeutic regimens that can eliminate active residual
tumor cells without activating dormant disseminated tumor cells, and this would significantly improve long-­term
metastasis prevention.

Public health relevance
The clinical benefit of chemotherapy has recently been cast in doubt because it has the potential to activate dormant disseminated tumor cells. Long- term functional assessment of therapy- induced tissue inflammation, remodeling and associated metastatic tumor cell biology is essential to develop better therapeutic regimens. The proposed tissue engineered implantable metastasis model represents a unique opportunity to capture the critical events during dormant- to- active transition of disseminated tumor cells while leveraging accumulated rich resources of mouse models for cancer research.